Core A: Administrative Core

Project Summary/Abstract – Core A
The Administrative Core, Core A, is the focal point for the four Projects and two other Cores comprising the
Program Project. As in the previous funding periods, Core A will reside on the Wichita State University (WSU)
campus with Drs. George Bousfield and Jeffrey May serving as Core A Lead and Co-Lead, respectively. Core
A will coordinate, facilitate, and integrate the activities of the Projects and Cores. Aim 1: Provide routine
administrative support to Project 4(Bousfield) and Core B(May), both located at Wichita State University,
and support Projects and Cores at the University of Colorado Denver Anschutz Medical Campus (UCD),
Aurora, CO, the University of Nebraska Medical Center (UNMC), Omaha, NE, and King’s College London
(KCL), UK as needed to prepare Research Performance Progress Reports (RPPRs) and grant
applications for this P01. Core A will provide routine administrative support to WSU participants and support
Projects and Cores at the three other project performance sites: UCD (Project 1: Kumar), UNMC (Project 2:
Davis and Core C: Guda), and KCL (Project 3: Jonas) as needed. Core A will work with administrative offices
at WSU to issue sub-awards and oversee budgetary matters regarding the two other regional campuses, UCD
and UNMC and one foreign campus, KCL. Aim 2: Coordinate communication among Projects and Core
Labs located at four separate institutions. Core A will organize the regular Program video conferences where
recent progress and research findings are discussed, and administrative issues are decided. Aim 3: Provide
oversight of Project via internal and external reviews. Core A will organize annual Program meetings
including: the External Advisory Committee (EAC) meeting which provides an opportunity for the Program’s
external committee members to come together with Project Leads, Core Leads, and others to review Program
progress and provide feedback; and the Spring Program Scientific Retreat where all research components of
the Program meet to review progress with the Internal Advisory Committee (IAC) and chart the next year’s goals.
Aim 4: Facilitate communication of results with scientific community. Core A will generate reports and
other paperwork relating to the Program Project for the NIH and institutional offices as needed. Core A will assist
in the preparation of manuscripts generated by the Projects as needed and will assess relevance of research
meetings for data presentation in consultation with the Projects and other Cores.